Probing the Formation and Function of Transcription Hubs

ABSTRACT
Transcription hubs are hotspots in the genome with elevated transcription activities.
Concentrating proteins and nucleic acids, transcription hubs are essential for cells to transcribe
genes important for cell identity and cell type-specific functions, while their dysregulation leads to
many diseases such as neurodegeneration and cancer. Although there is growing interest in
understanding transcription hubs, a lot remains unknown. The goal of our research is to address
two fundamental questions about transcription hubs, using advanced imaging and proteomics
techniques. The first of these questions is: how are transcription hubs formed? Transcription
hubs appear as distinct foci in the nucleus, and it is hypothesized that liquid-liquid phase
separation is responsible for transcription hubs formation. We will use Yes-associated Protein
(YAP) transcription hub, an ideal system established in my postdoctoral work to understand how
transcription hubs form. YAP is a transcription coactivator activating genes important in cell
proliferation and survival. After hyperosmotic stress, an inducible signal to activate YAP target
gene transcription, we have found that YAP forms hubs with different components over time,
coincident with their different functions (clustering accessible chromatins first, and activating
transcription second). We will use candidate and unbiased approaches to identify protein
components of YAP hubs with live-cell imaging, and then test the effect of modulating these
proteins in accessible chromatin organization and transcription activation. We will also use single
particle tracking to probe the biophysical nature of YAP transcription hubs, to understand if they
form by phase separation or alternative mechanisms. The second question regarding transcription
hubs is: how do transcription hubs activate transcription? We hypothesize that transcription hub
can mediate enhancer-promoter interaction to activate transcription. We will use multicolor live-
cell imaging to visualize localization of enhancer and promoter of Myc (a target gene of YAP), and
see how their relative position to YAP transcription hub lead to Myc transcription activation.
Together, these studies will elucidate molecular mechanisms of transcription hub formation and
function. A better understanding of these mechanisms will have implications for the formation and
function of other transcription hubs, and shed light on mechanisms of diseases of impaired
transcription hub formation.

Public health relevance
PROJECT NARRATIVE Transcription hubs are hotspots in the genome with elevated transcription activities. The proposed research seeks to understand how transcription hubs assemble on the endogenous DNA loci in cell, and how they engage with enhancer and promoter to activate transcription. This work will have implications to various diseases where transcription hub is dysregulated, such as neurodegeneration and cancer.